Determining how inflammation is regulated in RUNX1-Familial Platelet Disorder with Associated Myeloid Malignancies

PROJECT SUMMARY
RUNX1 Familial Platelet Disorder with associated myeloid malignancies (RUNX1-FPD) is caused by inherited
monoallelic mutations in the RUNX1 transcription factor. RUNX1-FPD patients have a high risk of developing
hematologic malignancies. Chronic inflammation is thought to play a central role in driving the risk for cancer in
RUNX1-FPD. As such, controlling inflammation may be an effective therapeutic strategy for preventing cancer.
However, the mechanisms by which mutations in RUNX1 promote an inflammatory state are incompletely
understood. We previously showed using genetic mouse models that loss of RUNX1 epigenetically
derepresses inflammatory signaling pathways in granulocyte-monocyte progenitors (GMPs). These epigenetic
alterations are inherited by neutrophils, which become primed to oversecrete cytokines. The epigenetic state
induced by loss of RUNX1 in GMPs strikingly resembles the proinflammatory epigenetic state of hematopoietic
stem and progenitor cells (HSPCs) in trained innate immunity (TII). In TII, exposure to pathogen or damage
associated molecular patterns induces HSPCs to undergo epigenetic remodeling that enables the innate
immune system to respond to these stimuli more robustly in the future. In contrast to the adaptive nature of TII,
complete loss of RUNX1 appears to induce a fixed and maladaptive proinflammatory state. The first goal of
this proposal is to establish whether RUNX1-FPD patients exhibit a state of fixed maladaptive innate immunity.
The second goal of this proposal is to determine whether and how the adaptive process of TII is altered in
RUNX1-FPD. I hypothesize that fixed maladaptive innate immunity caused by decreased RUNX1 levels
in hematopoietic progenitors will augment TII. I will test my hypothesis in a mouse model that faithfully
recapitulates RUNX1-FPD using a high fat diet model to induce TII. These studies will provide mechanistic
insight into the dynamic role that RUNX1 plays in regulating the inflammatory potential of the innate immune
system and may identify opportunities to therapeutically control inflammation.

Public health relevance
PROJECT NARRATIVE Germline mutations in RUNX1 cause RUNX1 Familial Platelet Disorder with associated myeloid malignancies (RUNX1-FPD), a cancer predisposition syndrome in which chronically elevated inflammation is believed to drive an increased risk for malignancy. To rationally develop therapeutic strategies that control inflammation and reduce the risk of cancer, we must first determine the mechanisms by which RUNX1 mutations promote an inflammatory state. This project seeks to address this gap in knowledge by determining how RUNX1 mutations influence how inflammatory programs are regulated in myeloid progenitors as the hematopoietic system adapts to an inflammatory stimulus.